Classical dendritic cells (cDC1) govern cardiac allograft tolerance

PROJECT SUMMARY
Acute and chronic rejection continue to represent serious challenges in transplant medicine. Current
medical regimens focus on suppressing T-cell responses, lack effectiveness for some patients and impose
significant risks of infection and malignancy. Recent studies have suggested that inhibition of co-stimulation
pathways between antigen presenting cells (dendritic cells, macrophages, B-cells) and T-cells may serve as an
effective strategy to prevent rejection by promoting allograft tolerance as opposed to simply suppressing
immune responses. This concept has garnered excitement across the transplant community and demonstrated
promising results in human renal transplant studies. A commonly used approach is inhibition of B7-CD28 and
CD40-CD40L costimulatory pathways. Blocking these pathways leads to prolonged allograft survival in fully
HLA-mismatched mouse heart transplantation models and non-human primates. There are important gaps in
knowledge pertaining to mechanisms by which co-stimulation blockade modulates the recipient immune
responses and confers donor organ tolerance. The precise immune cell populations and mechanisms
responsible for induction and maintenance of donor organ tolerance remain incompletely understood.
We have leveraged single cell RNA sequencing to dissect how traditional immunosuppression
(cyclosporine) and co-stimulation blockade (CTLA-4 Ig, anti-CD40L neutralizing antibodies) differentially impact
the immune landscape of the transplanted heart using a fully HLA-mismatched mouse model (Balb/c donor
heart à B6 recipient). Analysis of these datasets demonstrated striking differences between these treatment
regimens. Mice that received co-stimulation blockade displayed a marked increase in the abundance of
classical dendritic cells (cDC1s and cDC2s). Compared to the cyclosporine treated group, these cells
expressed high levels of negative regulators of T-cell stimulation including PD-L1. Using recipient mice that
lack either cDC1s or cDC2s, we found that cDC1s are absolutely required for co-stimulation blockade to confer
long-term allograft survival and prevent recipient immune responses against the transplanted donor heart.
This proposal seeks to elucidate mechanisms by which cDC1s prevent allograft rejection and
inflammation. The proposed experiments will identify chemokine pathways responsible for cDC1 trafficking and
delineate effector mechanisms by which cDC1s suppress effector T-cells.

Public health relevance
Project Narrative The ultimate goal of heart transplant research is to develop therapies that ensure long-term allograft survival while minimizing the need for immunosuppression. The proposed project focuses on investigating the role of classical dendritic cells (cDC1s) as mediators of allograft tolerance, particularly in the context of co-stimulation blockade. By exploring cDC1 phenotype, trafficking and effector mechanisms in preclinical models of heart transplant, this project seeks to uncover novel pathways of tolerance and identify cell-specific therapeutic strategies to improve transplant outcomes.